Mechanistic Connection between Interorganellar Communication and Obesity-associated Diseases

Project Summary
Obesity is a leading risk factor for type 2 diabetes, nonalcoholic fatty liver disease, and cardiovascular
diseases. A central driver of pathogenesis in obesity-associated disorders is the insufficient lipid-storing
capacity of adipocytes and subsequent lipid deposition in extra-adipose organs. The lipid droplet (LD) is the
organelle responsible for lipid storage and mobilization in adipocytes. It remains to be elucidated whether
proteins and pathways regulating LD structure and function constitute limiting factors governing the lipid-storing
capacity of adipocytes, and thus play an essential role in determining one’s susceptibility to obesity-associated
disorders. We observed that mice deficient in CLSTN3B, a mammalian adipocyte-specific protein, are more
prone to high-fat diet-induced metabolic disorders compared with body weight-matched wild-type mice,
whereas the adipose-specific clstn3b transgenic mice display the opposite phenotype. Preliminary evidence
shows that CLSTN3B localizes to endoplasmic reticulum (ER)/LD contact sites and ablation of CLSTN3B
results in an impaired coating of LDs by phospholipids and proteins. Our overall objectives are to (i) establish
the significance of CLSTN3B expressed in white adipocytes to the metabolic phenotype; (ii) reveal the
molecular mechanism of CLSTN3B action at the ER/LD contact sites. The central hypothesis is that CLSTN3B
enhances the structural and functional integrity of LDs, improves white adipocyte lipid-storing capacity, and
contributes to the maintenance of metabolic health under obese conditions; mechanistically, this is achieved by
replenishing LD surface phospholipids and promoting the binding of LD-targeting proteins. We will test this
hypothesis by pursuing three specific aims: 1) Show that CLSTN3B expressed in white adipocytes is the main
contributor to the metabolic benefits upon high-fat diet feeding; 2) Show that CLSTN3B promotes
phospholipids transfer between ER and LD; 3) Probe the role of the C-terminal ER luminal segment of
CLSTN3B in the formation of ER/LD contacts. For the first aim, we will construct genetic models allowing
specific assessment of white adipocyte-derived CLSTN3B. For the second aim, we will design in vitro
reconstituted phospholipid transfer assays and examine the functional significance of LD surface phospholipid
density. For the third aim, we will use biochemical approaches to identify potential binding partners of the ER
luminal C-terminal fragment of CLSTN3B, followed by assessing the significance of such interactions using
cellular and animal models. The proposed research is innovative because it dissects the molecular mechanism
of a novel protein and explains susceptibility to obesity-associated disorders from a novel perspective. The
proposed research is significant because it aims to establish an integrated understanding encompassing
interorganelle communication and metabolic physiology at the organismal level. Our long-term goal is to use
CLSTN3B as a molecular handle to derive a thorough understanding of ER/LD interactions in the specific
context of adipocytes and identify novel therapeutic targets for obesity-associated diseases.

Public health relevance
Project Narrative The proposed research aims to define the physiological role of a novel adipocyte-specific protein CLSTN3B in determining the lipid storing capacity of adipocytes and the detailed molecular mechanism underlying this function. The knowledge obtained from this research is relevant to public health because factors affecting the lipid storing capacity of adipocytes are closely associated with an individual’s susceptibility to developing metabolic complications as a result of extra-adipose lipid deposition under the condition of caloric overload. Thus, the proposed research is relevant to the NIDDK’s mission of seeking fundamental knowledge about endocrine and metabolic diseases and using that knowledge to improve people’s health and quality of life.